Measuring and Mapping National Pediatric Acute Care Outcomes

PROJECT SUMMARY/ABSTRACT
Across 25 million emergency department (ED) visits annually, children experience widely variable care due to
major differences in readiness and capabilities between EDs. These differences bear on the likelihood that a
patient will receive an accurate diagnosis and timely, high-quality treatment. Measuring outcomes across the
entire national pediatric acute care system has proved difficult because granular, national, geocoded
healthcare data have been unavailable; investigators have focused on individual diseases; regional healthcare
maps are outdated; challenges abound with risk adjustment for individuals’ personal risk; and because each
disease requires a different approach to measure its outcomes. Further complicating efforts is the complex
network of relationships between hospitals in which multiple facilities share responsibility for outcomes. These
relationships are substantially different between adult and child patients, and there is no working understanding
of the structure of the national pediatric network. This proposal will overcome those challenges to create the
Atlas of Pediatric Acute Care, a comprehensive examination of the acute care outcomes of 37.7 million
children across the nation, which represents half of the US child population. The Atlas will map regional
hospital systems using sophisticated network analysis algorithms known as community detection. The map
that results will define regions of pediatric care in which there is a shared responsibility for care. It will be used
to determine regional outcomes across three serious conditions in children: appendicitis (the most common
surgical condition in children), neurotrauma (the most common cause of serious injury), and sepsis (a
notoriously difficult-to-diagnose condition that is one of the costliest). This knowledge will then provide the
basis to compare regional systems to elucidate the factors associated with high performance. We will also use
the highest-quality methods to understand costs, using actual patient and payer expenditures, across US
pediatric regions. This proposal reflects the priorities of the Eunice Kennedy Shriver National Institute of Child
Health and Human Development: to use “large-scale datasets to optimize outcomes for traumatized, injured,
and critically ill children” and to “examine the epidemiology and treatment of all forms of critical illness.”
Focusing efforts to improve outcomes nationally has the potential to improve the population health, but
depends on an accurate, multi-disease understanding of outcomes. The Atlas will provide such an
understanding and will emerge as an enduring resource to support efforts to improve pediatric acute care,
which will translate to better survival and higher quality of life for the nation’s children.

Public health relevance
PROJECT NARRATIVE Millions of children visit emergency departments each year with variable access to pediatric expertise, and it is currently unclear how the sickest children fare. Ensuring the best outcomes in pediatric acute care is a national public health priority and depends on understanding variability in hospital quality. To understand where in the nation outcomes could be improved, we will use sophisticated whole-nation network analysis to develop a comprehensive atlas of national pediatric acute care outcomes, which we will then use to compare outcomes in three of the most common serious pediatric diseases: appendicitis, neurotrauma, and sepsis.